Trajectories of Behavioral Inhibition and Risk for Anxiety

The parent grant, Trajectories of behavioral inhibition and risk for anxiety (U01MH093349), examines the developmental pathways from early fearful temperament, Behavioral Inhibition (BI), to anxiety emerging during late adolescence. Although BI is one of the best early predictors for later anxiety, not all children with a history of BI go on to develop clinically significant anxiety, making it critical to identify the mechanisms that differentiate adolescents who struggle from those who adapt. To understand variability in outcomes, the parent grant examines how specific internal (e.g., reactive vs proactive cognitive control) and external (e.g., supportive friendships) factors, assessed during mid-adolescence (age 15), serve to exacerbate or mitigate responses to social challenges. Finally, the parent grant examines the link between response to social challenges at age 18 and the development of psychopathology by late adolescence (age 18), within a large sample of adolescents. Specifically, social interactions between the target participants and unfamiliar peers are observed, information regarding social relationships is obtained, and psychiatric status is evaluated. This administrative supplement requests funds for subject compensation so that we may conduct the social interactions, administer questionnaires regarding social relationships and evaluate psychiatric status on-line as opposed to in the lab.

Public health relevance
Project Narrative The specific aims of the current project are to examine social interaction and social relatedness in a sample of adolescents who were characterized early in life for Behavioral Inhibition (BI). BI is one of the best phenotypes for the emergence of anxiety and specifically social anxiety. In this proposal, we will conduct social interactions via Zoom as it is not possible to see the participants in the laboratory. We will as well have the participants complete questionnaires and we will conduct a psychiatric screen (SCID) on the sample.